Electrical stimulation to control feedback modulation of perception

SUMMARY
Visual perception is a confluence of visual input and attentional state. How visual inputs are processed and
represented in human visual cortex is being captured with increasing accuracy in the field. However, a critical
gap in our understanding is how top-down inputs from higher order areas influence and sculpt sensory
processing—especially an understanding grounded in direct causal manipulations. The long-term goal of the
proposed research is to develop causal perturbation methods that modulate visual processing in ways that
mimic attentional processes. To achieve this goal, we will use electrical stimulation to test, refine, and extend
a quantitative model of feedback information flow to the ventral temporal cortex (VTC). Our research
leverages a recent clinical shift in epilepsy surgery from brain surface recordings with electrocorticography to
stereo-electroencephalographic (sEEG) depth electrodes: sEEG provides unique opportunities to measure
VTC and electrically stimulate feedback projections from gyral and sulcal parietal, frontal and anterior
temporal regions as well as the white matter pathways that connect these areas to VTC. In Aim 1, we will
determine how stimulating these different feedback locations affects neuronal activity in VTC and simulate
VTC signals in a model of a cortical column. VTC electrodes will be localized functionally with a scene
perception task and structural connections will be identified from preoperative diffusion MRI measurements
on Mayo Clinic’s novel compact 3T scanner with high performance gradients and distortion free imaging. In
Aim 2, we will determine the optimal stimulation frequencies for feedback pathways to VTC. Electrodes in
feedback pathways will be stimulated with different temporal frequencies and measurements in VTC will be
used to characterize optimal response frequencies. In Aim 3, we will test predictions of a previously proposed
model of feedforward drive and feedback modulation in VTC. We will present visual scenes while delivering
electrical stimulation of feedback pathways and measure changes in sEEG neural responses and behavioral
reaction times. This combination of electrical stimulation and visual perception allows us to test and refine an
extant model of how interactions between VTC and the intraparietal sulcus affect visual processing and
contribute to visual perception. Overall, this multidisciplinary proposal will deliver a set of empirical
measurements and models that describe the causal influence of feedback pathways on human VTC. These
studies will provide the groundwork for future research to design perturbation based strategies that mimic
human attentional conditions.

Public health relevance
PROJECT NARRATIVE Perception reflects a combination of sensory drive from the periphery and inputs from central brain regions. This proposal will use electrical brain stimulation to control inputs from cognitive brain areas that project to the ventral visual pathway in the human brain, and measure and model how these projections influence the representation and perception of complex visual stimuli. These studies will provide the basis for future research to design perturbation based strategies that mimic human attentional conditions.